Engineering the next generation nanoparticle-cyclosporine A therapy in lupus

Project Summary
Systemic lupus erythematosus (SLE) is a debilitating autoimmune disease that can affect almost every organ
in the body. Current treatments for SLE are often inadequate because they involve the chronic use of non-
specific, steroidal and cytostatic drugs that are associated with a wide spectrum of side-effects. However,
notwithstanding ongoing efforts to develop better therapies, there has only been one new, FDA-approved drug
for SLE in more than five decades. In this context, cyclosporine (CsA), a powerful suppressor of both humoral
and cell-mediated immune responses can be a potential candidate, but its efficacy as a stand-alone treatment
for SLE has never been demonstrated and often used to steroid tampering. Acknowledged reason for the lack
of success with the current commercial CsA formulations is due to poor/variable target (lymphoid) tissue
bioavailability with consequently differing biological activity and toxic to the kidneys. Targeting the lymphoid
tissue potentially enables rational design of therapeutics to modulate the immune system, representing an
innovative approach to treating lupus due to the fact that more than 75 percent of immune cells reside in the
GUT-associated lymphoid tissues (GALT). Moreover, GALT in lupus is larger compared to the healthy
individuals, making it an attractive site for targeting. The proposed study will generate paradigm-shifting, new
knowledge in the field of nano-medicines using unique periodic-functional-polyesters (P2s, unlike commercial
PLA/PLGA that are terminal functional), and investigate how the ligand density and composition influence the
CsA delivery to lymphoid tissue. The work is enabled by previous findings, in which highly potent lymphatic
system-targeting nanoparticle-CsA (called P2Ns-GA-CsA) specific to CD71 (transferrin receptor 1, TfR-1) on
lymphoid cells (T and B-cells) have outperformed ligand-free controls and commercial CsA product, leading to
better therapeutic outcomes. In this project, the technology is further developed by investigating how the
spatial size and composition of the spacer molecules affect the intestinal-receptor interaction and transport of
the nanoparticles facilitating customized dose-regimens. The project comprises of the following three aims,
Aim#1, to establish structure-activity relationships for P2Ns-GA-CsA in a murine lupus and TfR KO models.
Aim#2, to define the therapeutic dose of P2Ns-GA-CsA in a murine lupus model and Aim#3, to establish
survival rates in murine lupus models using the most efficacious P2Ns-GA-CsA.

Public health relevance
Project Narrative WHO estimates that there are currently 5 million humans living with some form of lupus. There is a great need for developing effective therapies for lupus, a condition that is difficult to diagnose and treat due to variability of symptoms from person to person. The goal of this grant is to engineer highly potent lymphatic system-targeting nanoparticles for customized delivery of cyclosporine, an immunosuppressive drug often used as last option due inherent shortcomings of conventional formulations, such as poor lymphoid targeting and toxicity.